MEDICINAL CHEMISTRY SERVICES TO SUPPORT PROJECT "ALDRICH (UNIV. OF FLORIDA) - EXPLORATORY CHEMISTRY-ADMET ONLY - MCSP"

MEDICINAL CHEMISTRY SERVICES TO SUPPORT PROJECT "ALDRICH (UNIV. OF FLORIDA) - EXPLORATORY CHEMISTRY-ADMET ONLY - MCSP"